Administrative Core

Abstract LSUHSC CARC Administrative Core
The purpose of the Louisiana State University Health Sciences Center (LSUHSC) New Orleans Comprehensive
Alcohol-HIV/AIDS Research Center (CARC) is to conduct cutting-edge translational research on the impact of
alcohol use disorders (AUD) on biomedical and psychosocial comorbid conditions of persons with HIV (PWH).
The goal of the CARC is to generate evidence-based knowledge on the interaction of alcohol and HIV disease
that will inform health care providers and will lead to effective primary care-based interventions to decrease
comorbidity risk and improve health outcomes of PWH. The Administrative Core of the CARC will provide
oversight and the organizational framework for the direction, management, and coordination of all activities.
Specifically, the Administrative Core will; 1) monitor the performance and productivity of the individual research
components (RCs) and cores; 2) manage the budget and fiscal activities of the CARC; 3) supervise the CARC
personnel; 4) provide support for data collection, management, and analysis, and 5) provide oversight for the
educational, enrichment and dissemination functions of the CARC. In essence, the Administrative Core is
responsible for centralizing, coordinating, and integrating research and administrative components of the CARC.
Dr. Molina, Principal Investigator and Director, and Dr. Edwards, Associate Director of the Administrative Core,
will direct all CARC-related activities in consultation with the Intramural Center Committee (ICC), formed by the
leaders of each RC. The Administrative Core will facilitate logistics for synergistic, productive, and seamless
interaction among the participants to substantially enhance the success of CARC activities. The Administrative
Core will foster formal and informal exchanges among members of the CARC and the intra- and extramural
scientific community, including the External Advisory Committee (EAC) to allow for peer-review, idea cross-
fertilization, and development of new collaborative projects focused on the biomedical health consequences of
AUD in PWH. The Administrative Core is a mature, integrated component of our CARC with a successful record
in supervising, promoting, and developing comprehensive, thematically focused, research programs that
maximize the benefits of the scientific infrastructure provided by CARC.

Public health relevance
Narrative LSUHSC CARC Administrative Core The Louisiana State University Health Sciences Center (LSUHSC) New Orleans Comprehensive Alcohol- HIV/AIDS Research Center (CARC) conducts cutting-edge translational research on the impact of alcohol use disorders on comorbid conditions affecting persons with HIV (PWH). The goal of the studies is to generate evidence-based knowledge that will inform health care providers and will lead to effective primary care-based interventions to decrease comorbidity risk and improve health outcomes of PWH. The Administrative Core of the CARC will provide oversight and the organizational framework for the direction, management, and coordination of all activities